Rapid and responsive development of "spice" sensors using a novel recognition scaffold

PROJECT SUMMARY
Over the past decade, synthetic cannabinoids that intend to mimic the effects of cannabis use have emerged
as an important group of New psychoactive substances (NPSs) sold as “legal high” products under brand
names such as “Spice”, “Black Mamba”, and “Annihilation”. These compounds are more potent and dangerous
agonists than those found in cannabis and they have caused a variety of adverse health effects, including
psychoses, hospitalizations, and deaths. In response, the DEA has placed 43 synthetic cannabinoids under
Schedule I classification; however, new synthetic cannabinoid ingredients are regularly created and released to
both evade legal restrictions and provide a product that avoids detection by routine drug screening tests.
Although GC/LC-MSn can be used to comprehensively detect these agents, the vast majority of forensic and
clinical labs rely on immunoassays for their drug tests due to simplicity and cost. New methods that accelerate
the development of diagnostic for the ever-changing substances of abuse would be useful, both for addressing
the synthetic cannabinoid problem and as a general technology. We propose to address this challenge by
developing a new platform for rapid assay development that functions orthogonally to immunoassays. To do
this, we propose to use directed evolution to reprogram the ligands sensed by the plant PYR1-PP2C stress
hormone sensing system. This sensor functions through a naturally occurring chemical-induced dimerization
(CID) mechanism that couples ligand recognition by PYR1 to the formation of a stable PYR1-PP2C complex;
this feature facilitates genetic selection experiments for receptors that recognize new ligands. We hypothesize
that our platform will enable rapid development cycles for new diagnostics. To prove this hypothesis, this
exploratory study will (1) Develop receptors for selective recognition of synthetic cannabinoids through
directed evolution, (2) Integrate target recognition and signal output using protein fragment
complementation assays, and (3) Establish and validate synthetic cannabinoid detection systems in
biological matrices. Sensors will be designed to detect multiple synthetic cannabinoids, prioritizing the most
prevalent synthetic cannabinoid of 2020 (5F-MDMB-PICA), which is not detected by current clinical
immunoassays. The feasibility of this proposal is backed by extensive preliminary data from the PI’s laboratory,
which demonstrates that the PYR1-PP2C system can be used to evolve high-affinity synthetic cannabinoid
sensors. Our long-term goal is to establish this new system for the rapid development of diagnostic tools and
deliver reagents that enable fast and selective detection of synthetic cannabinoids in low volumes of biological
specimens. These enabling tools will be valuable for biomedical and clinical analyses of synthetic
cannabinoids to control drug abuse, improve treatment and diagnosis of intoxication, to characterize their
pharmacological and health effects, and as a general platform for rapidly evolving new diagnostic assays.

Public health relevance
Project Narrative Synthetic cannabinoids are the most commonly abused New Psychoactive Substances, and increasingly reported to cause a variety of adverse health effects. Since many synthetic cannabinoids escape detection by immunoassay-based drug screening tests, we propose to solve this challenge by evolving and employing plant receptors for selective and sensitive detection of synthetic cannabinoids in biological matrices. The proposed enabling technique can deliver a fast and simple technological platform for rapidly creating diagnostics for new psychoactive substances as they emerge in the marketplace, to control drug abuse, improve the treatment and diagnosis of intoxication, and to help proper evaluation of their impacts on human health.